Reference strains of Mycobacteroides abscessus

PROJECT SUMMARY
In cystic fibrosis, bronchiectasis and chronic obstructive pulmonary disease patients, non-tuberculous
bacterium Mycobacteroides abscessus can cause chronic pulmonary disease that is often incurable and
associated with rapid lung function decline. Additionally, existing treatment requires more than a year of daily
intake of antibiotics with poor efficacies and significant toxicities. M. abscessus has been designated as an
“antibiotic nightmare” and “an environmental bacterium turned clinical nightmare” due to extensive natural
and acquired antibiotic resistance, which severely limits treatment options.
Although the NIH recently declared M. abscessus as an emerging pathogen of interest, it is one of the least
studied organisms. The overall aim of this proposal is to identify two clinical M. abscessus isolates that were
recently derived from cystic fibrosis, bronchiectasis or chronic obstructive pulmonary disease patients and
are representative of the strains relevant in the present context so that they can be used as reference strains
in research. The historical M. abscessus strain that is currently used as the default reference strain was
isolated in 1953 from a knee abscess. Therefore, it is unknown how relevant the data obtained using this will
be to pulmonary infections and drug susceptibilities to strains prevalent today. Our central hypothesis is that
reference strain(s) should represent current clinical isolates. We postulate a relevant reference strain is
necessary for rigorous research so that the data obtained will be more applicable to M. abscessus infections
in cystic fibrosis, bronchiectasis and chronic obstructive pulmonary disease patients.

Public health relevance
NARRATIVE Rapid-growing nontuberculous bacterium Mycobacteroides abscessus is recognized as an emerging pathogen for individuals with underlying structural lung conditions such as bronchiectasis, cystic fibrosis and chronic obstructive pulmonary diseases. The historical M. abscessus strain that is used as the reference strain, ATCC 19977, was not isolated from lung infection and therefore may not be predictive of recent M. abscessus strains that largely cause lung infections. We will compare this strain with several recent strains isolated from lung infections and identify the most representative strain as the reference strain.